Circadian and homeostatic regulation of sleep in a diurnal model of Smith-Magenis Syndrome

ABSTRACT
Sleep maintains brain structure and function, but more than 1 in 4 individuals with neurodevelopmental
disorders exhibit sleep disturbances. These sleep problems exacerbate difficult behavior such as aggression
and self-injury and improved sleep improves them. Unfortunately, the neural mechanisms underlying such
disordered sleep in neurodevelopmental disorders remain unknown. Interestingly, many genes causal for
monogenic neurodevelopmental disorders encode transcriptional regulators that can influence circadian gene
expression. In Smith-Magenis syndrome (SMS) in particular there are other indicators of a strong role for
circadian influences on sleep/wake dysfunction: namely a reversed daily cycle of melatonin and altered
function of melanopsin, the photoreceptor mediating non-visual effect of light. In this syndrome, human
patients show reduced daytime wakefulness and reduced nighttime sleep, quite possibly consistent with these
melatonin cycle abnormalities and/or impairment in melanopsin-mediated light response. Despite this initial
suggestive evidence, it remains unclear how light or melatonin contributes to sleep/wake alterations in this
condition. Using CRISPR-based gene editing in Nile grass rat, Arvicanthis niloticus, we have developed a
diurnal rodent model of SMS by targeting Rai1, the casual gene for the disorder. Preliminary data in Rai1-KO
grass rats showed disrupted daily rhythms and sleep disturbances, mimicking the human phenotype. The
proposed study will further characterize the effects of Rai1 deficiency on sleep and neural network, and test the
central hypothesis that RAI1 haploinsufficiency disrupts light and/or melatonin-based regulation of sleep
rhythm and neural network function in diurnal mammals, in the following specific aims: Aim1 will determine the
role of RAI1 in daily sleep/wake rhythms neural network properties. We will determine the role of RAI1 in a)
daily sleep/wake rhythms using electroencephalography (EEG) and electromyography (EMG), as well as in b)
daily modulation prefrontal cortical network spiking dynamics recorded with silicon probes. Aim 2 will test the
hypothesis that sleep disturbances in Rai1-KO grass rats are due to impaired photic input, based on elevated
daytime melatonin, excessive daytime sleepiness, and altered pupillary reflex indicating dysfunction in
photoreceptor melanopsin reported in SMS individuals. To test this, we will a) house both KO and WT animals
in constant darkness housing (remove photic cue), and b) maximize melanoptic stimulation using full-spectrum
daylight (replenish photic input, Aim 2B). Aim 3 will test the hypothesis that sleep disturbances in Rai1-KO
grass rats are due to altered melatonin rhythm. We will first remove melatonin by pinealectomy, followed by
day or night melatonin infusion using a programable minipump. Sleep/wake and network electrophysiologic
function will be measured to determine how light or melatonin contributes to the sleep phenotypes and network
properties in SMS . This work will shed light on neural mechanisms of sleep disturbances in SMS, and lead to
novel interventions to improve sleep in patients of SMS and other neurodevelopmental disorders.

Public health relevance
PROJECT NARRATIVE Smith-Magenis Syndrome (SMS) is a genetic disorder with cognitive, behavioral, circadian activity and sleep disturbances, and sleep disturbances can worsen behavioral and cognitive symptoms. Leveraging here a recently developed diurnal rodent, we will investigate the neural mechanisms underlying the sleep disturbances in SMS. The results will contribute to better understanding of the neural mechanisms and to the development of novel interventions for sleep problems in SMS and other neurodevelopmental disorders.